Global Health Reciprocal Innovations SWG

Modified Project Summary/Abstract Section

Global health reciprocal innovation (GHRI) is a recently coined term to describe a new framework for bidirectional, iterative exchange of technology, methodology, and/or processes between countries with fewer resources and those with more resources to address shared health challenges. The UAB CFAR has an energized and growing number of researchers who are poised to become leaders in the use of GHRI to tackle challenges in the field of HIV because of (a) UAB’s longstanding partnerships in less resourced countries, (b) the stark and persistent gaps in HIV treatment and prevention in the U.S. Deep South, and (c) shared characteristics of the HIV epidemics in less resourced countries and the U.S. Deep South. The GHRI Scientific Working Group (SWG), led by two NIH-funded UAB faculty who have experience translating HIV innovations between less resourced countries and the U.S. Deep South, will catalyze new HIV research at UAB that uses GHRI, by implementing three specific aims. The SWG will create a new scientific platform (Aim 1) for scientific exchange and training in GHRI. Networking opportunities (Aim 2) will be created to link researchers working on similar challenges in HIV in different geographical areas and increase engagement in GHRI. Finally, the SWG will catalyze and support novel HIV-related projects (Aim 3), working in conjunction with other global health-oriented cores and centers at UAB to support bidirectional teams to obtain pilot funding and provide tailored consultation and training around extramural grant opportunities that can support HIV-related projects that feature GHRI. SWG members will include both UAB researchers, as well as HIV researchers/implementers at a range of local (U.S. Deep South) and global partner institutions, whose involvement will be strongly valued.